Enhancing insight into placental dysfunction in common obstetric disorders using placental multiomics

Project Summary
Adverse obstetrics disorders, including preeclampsia, preterm birth, and fetal growth restriction, are
common worldwide. However, they are difficult to study given multifactorial etiologies and co-occurrence
of disorders. Placental dysfunction has a role in these diseases but the underlying molecular
mechanisms are not well understood. Integrated multiomic analysis can address this gap by identifying
underlying molecular mechanisms associated with individual disorders and combinations of disorders.
The goal of this study is to advance mechanistic understanding of the molecular networks associated
with obstetric disorders, to identify and prioritize new directions for future research for improving
maternal-fetal health. We propose to find patterns at the individual, network, and system levels that shed
light on mechanisms of disease associated with normal placental physiology and placental dysfunction.
The Sadovsky lab has provided de-identified metabolomic, proteomic, and transcriptomic placental data
paired with histopathology reports and clinical data including demographics, routine clinical labs,
maternal comorbidities, and delivery records. These data come from 333 placentas from people with
singleton pregnancies, including uncomplicated term pregnancy, fetal growth restriction, preeclampsia,
fetal growth restriction with a hypertensive disorder, and spontaneous preterm birth. The analyses in this
proposal are complementary to, and distinct from, those in a separate K99. In Aim 1, we will define
placental physiological association networks to determine placental regulation. We have preliminary data
for pairwise associations between analytes and placental histopathological features using generalized
linear models. We will conduct community structure analysis on these associations to identify
subnetworks of placental regulation and evaluate differences in network identity and structure. For each
obstetric disorder, we will also evaluate the contribution of top interconnected community networks to
regulation of placental physiology by evaluating model robustness and multicollinearity. This will provide
domain-agnostic detection of patterns of systems-level placental regulation. In Aim 2, we will determine
molecular network differences among obstetric disorders. We have evaluated pairwise differences
between individual analytes between phenotypes, and we will build on this work by evaluating placental
network differences between different obstetric outcomes in two ways: determining the network structure
differences between phenotypes, and building and evaluating classification models for obstetric
disorders. We will then perform case-study outlier analysis to provide potential molecular insight into
placental dysfunction on the individual level. This will provide molecular network understanding of
placental regulation and how it’s disrupted in obstetric disorders at the population and individual level.

Public health relevance
Narrative The placenta is an essential organ for healthy maternal-fetal outcomes. However, molecular mechanisms of placental dysfunction in obstetric disorders are not well understood. We will conduct statistical analysis on data from observations of placental tissue (metabolites, proteins, transcript RNA, and histopathology), together with clinical data from patients' charts. This study of the underlying mechanisms of placental health and disease aims to find and help prioritize new areas of research for improving obstetric outcomes.